Network for Cardiothoracic Surgical Investigations in Cardiovascular Medicine

Project Summary
Cardiac surgery has been a highly innovative field of medicine. The introduction of major innovations, and
ongoing incremental change in existing ones, have extended survival and improved quality of life for many
patients suffering from cardiac disease. A rapid pace of innovation requires a rigorous infrastructure for clinical
evaluation that provides timely assessments of the value of new and modified treatments. The Cardiothoracic
Surgical Trials Network (CTSN) was created to provide a rigorous evidence base tor the surgical treatment of
cardiothoracic disease.
The International Center for Health Outcomes and Innovation Research (InCHOIR) enthusiastically embraces
the opportunity to continue to work in partnership with clinical investigators and the NIH as the CTSN DCC.
The Network has developed a rich research agenda for the renewal that includes trials of novel neuroprotective
agents, long-term antithrombotic strategies, new regenerative medicine therapies, and surgical approaches to
valvular disease, heart failure and atrial fibrillation. Given our long-standing interest and experience in the
design and analysis of cardiac surgery multicenter studies, we are in a strong position to serve as the
coordinating center for this vital clinical research effort.
In particular, we will provide leadership in designing novel trials that optimize sample size, include patient-
centered as well as clinical endpoints, and collect data from a variety of sources, including electronic data
capture systems, mobile apps and wearable sensors, registries and electronic health records. We have a
strong track record of obtaining efficient regulatory approval for our trials from the FDA and Health Canada,
training and monitoring sites nationally and internationally, ensuring robust enrollment and retention, data
management and quality assurance, data sharing, and overall administrative coordination. We have the
infrastructure to expand our trials to include mechanistic studies that use biospecimens collected and managed
through the CTSN biorepository. Finally, the DCC plays an important role in the analysis, interpretation and
dissemination of research findings. We will continue to support the process of publishing in high-impact
journals that should lead to revision of practice guidelines and to surgical practice itself. This goal should be
further optimized by incorporating Implementation Science approaches into Network trials, which should
decrease the well-recognized gap between publication of trial results and adoption of findings into widespread
practice.

Public health relevance
NARRATIVE Clinical trials are a critical step in translating discoveries into better treatments for people burdened by cardiac disorders. Such trials typically require cooperation and coordination among a broad range of investigators, patients, government agencies, and industry partners. The objective of the Cardiothoracic Surgical Trials Network (CTSN) is to increase the effectiveness and efficiency of clinical research through shared infrastructure for important trials that will advance therapy for patients suffering from cardiac disease.